Administrative Core

This Administrative Core will oversee the coordination of the four component projects of this overall application. The core will organize regular working meetings to discuss findings and future directions across the projects. The Core will also organize visits of the External Advisory Committee on alternate years. The External Advisory Committee includes: Drs. Mary-Jeanne Kreek (The Rockefeller University), Peter Kalivas (Medical University of South Carolina) and Marc Caron (Duke University). These advisors have all agreed to serve.